Arterial stiffness in mother/infant dyads: Life course approach to prevent cardiovascular disease

ABSTRACT
Greater than 45% of women in the United States experience excessive gestational weight gain (GWG) leading
to increased cardiovascular disease (CVD) risk during pregnancy, postpartum and beyond (≥10 years). Excess
fat accumulation and specific fat distribution patterns, such as abdominal visceral fat, accelerate vascular aging
in the general population. However, the composition of GWG is scarcely reported. Therefore, a knowledge gap
exists in understanding whether the vascular aging response is associated with changes in body composition
and fat distribution during pregnancy and postpartum. This proposal supplements the Mother and Infant
Determinants of vascular Aging Study (MIDAS; R01HL157075). The MIDAS study will enroll 840 racially and
ethnically diverse healthy and medically complicated mother/infant dyads between 34-40 weeks gestation. At
34-40 weeks gestation, within 48 hours of delivery, and at 6 and 12 months postpartum, the MIDAS study will
assess vascular aging and CVD risk by measuring pulse wave velocity (PWV), and examine relationships
among biologic, personal, social, and ecological disease risk factors with PWV. The objective of this proposal
is to elucidate how body composition (Aim 1) and fat distribution (Aim 2) changes during and following
pregnancy impact postpartum CVD risk. Although obesity, defined by body mass index, is a proposed
modifiable risk factor, body composition (i.e., %fat) and fat distribution (i.e., visceral adipose tissue) were not a
focus of the parent grant. Therefore, this proposal will complement the existing MIDAS study by leading the
data collection and in-depth analysis of gestational and postpartum body composition. The study specific aims
are: 1) determine the association between the trajectory of %fat from 34-40 weeks gestation to 12 months
postpartum and PWV at 12 months postpartum in 840 racially and ethnically diverse pregnant women, and 2)
determine the association between the change in fat distribution from 6 to 12 months postpartum with PWV at
12 months postpartum in a subset of women (n=280). We will also explore whether race moderates the
proposed associations in Aims 1 and 2; racial and ethnic minority women have a greater prevalence of obesity
and are at a greater risk for pregnancy complications and CVD compared with non-Hispanic white women.
This time sensitive supplement leverages access to a large, diverse cohort of pregnant and postpartum women
and a multi-disciplinary team of mentors with expertise in CVD risk and maternal health. As a result, we are
well positioned to complete the proposed aims. Additionally, this supplement will enable an early career
investigator to: 1) gain experience conducting a well-defined research project evaluating CVD risk in pregnant
women, 2) develop her grantsmanship and, 3) expand her research network and learn from a successful
mentorship team. This supplement will be an integral component to the MIDAS study by focusing on adiposity-
related risk to maternal cardiovascular health and it will provide an early career investigator with support to
advance her career trajectory and establish an independent, fundable research line.

Public health relevance
PROJECT NARRATIVE In pregnant and postpartum women, there is a lack of data addressing biological, social, personal and ecological cardiovascular disease risk factors. Obesity, defined by excess fat accumulation and high body fat percentage, can be modified to prevent accelerated vascular aging and subsequent cardiovascular disease risk. This supplement will leverage the Mother and Infant Determinants of vascular Aging Study (MIDAS; R01HL157075), which will enroll a diverse cohort of mothers with healthy and complicated pregnancies, to determine whether changes in body composition and fat distribution during pregnancy and postpartum is associated with vascular aging.